NH PHL Discipline B Chemistry Analytical Track 2 - human food product testing

Discipline B: Chemistry Analytical Track 2: Human Food Product Testing The NH PHL plans to improve food testing surveillance programs in New Hampshire through the chemical analysis of food products. The test results generated by these analyses can be used to remove adulterated food from commerce and aide regulatory inspection programs in the New Hampshire Bureau of Food Protection in conducting investigations. The NH PHL plans to perform toxic metals analyses by ICP-MS analysis following CHE.0009, to ensure compliance with toxic element action levels. The following commodity/hazard pairs will be analyzed; Commodity Hazard Class II Dairy Products Total Arsenic Apple juice, ciders, imported spices Toxic elements The NH PHL will analyze a minimum of 210 Class II Dairy Products, ensuring a complete study of this local commodity that is transported across state lines. The additional 50+ samples of local and imported spices, juices and ciders and other FDA regulated commodities will assist both the local communities and the FDA when combined with data from other testing sites to ensure quality and safety in the food products originating in the State of New Hampshire. NH PHL will participate and pass annual proficiency tests, attend the LFFM Face-to-Face meeting and monthly Food Emergency Response Network (FERN) calls, maintain ISO 17025 accreditation of CHE.0009, maintain facilities and personnel necessary to complete the work proposed, and provide a detailed quarterly summary of all samples collected and analyzed. The NH PHL will maintain a valid 20.88 agreement with the FDA. Sampling will be conducted by the NH Bureau of Food Protection, the official agency overseeing dairy farms and plants in the State of New Hampshire, following standard FDA-approved practices.

Public health relevance
Project Narrative - Discipline B: Chemistry - Analytical Track 2: Human Food Product Testing The New Hampshire Public Health Laboratories (NH PHL) will improve food testing surveillance by performing a complete study of Class II Dairy products, as well as other local New Hampshire products, for the presence of toxic metals. The activities of the NH PHL will allow for removal of adulterated food products from commerce and aide in the New Hampshire Food Protection Program's regulatory inspection programs, ensuring compliance with toxic element action levels.